Defining and Controlling Airway Disease

Abstract
Airway epithelial cells were originally regarded as an inert barrier to the environment, but are now viewed as key
regulators of the response to injury and infection with a critical role in airway repair that mimics lung development.
Furthermore, altered behavior of this cell population is central to the pathogenesis of common airway diseases
such as asthma and COPD, making it essential to understand the mechanisms responsible to normal and
abnormal programming of this cell population. My research program is thematically focused on airway epithelial
cell programming with the goal of characterizing the molecular basis of airway epithelial cell function and
dysfunction for airway homeostasis versus disease. Our work to date has contributed to new paradigms in airway
epithelial cell biology, including the first evidence of an active role for airway epithelial cells in directing the
immune response towards airway disease and now the first data for an elusive airway progenitor epithelial cell
(APEC) population that can be respiratory-virus activated to orchestrate disease and thereby explain how a
transient infection could lead to long-term disease. Building on this work, we will focus going forward on creating
a new concept for tissue homeostasis versus disease based on a set of transformative paradigms where
progenitor cell reprogramming switches a normal airway epithelial barrier to one dominated by mucus production
and the consequent morbidity and mortality of airway disease. We will provide the first definition of the key
population of airway progenitor epithelial cells and the first mechanisms for how these cells are switched to
disease-producing cells, incorporating unprecedented roles for: (1) endogenous viral, water channel, and
nucleokine control of mitotic chromatin in these cells; and (2) an exogenous danger loop from these cells to
immune cells and back to drive a distinct progenitor-cell kinase now targeted with structure-based drug design
to interrupt mucus production. Translational impact also derives from new mouse and pig models and validation
in humans with comparable disease. This substrate is combined with new approaches to cell isolation, 3D
manipulation, and transplantation based on targets identified from genomic and proteomic analyses. Each of the
individual approaches within the overall Program is charged to investigators in training to integrate scientific
career development into the mission for medical research and discovery. In addition, the Program relies on vital
and sophisticated input from senior pulmonary scientists for additional mentoring and cutting-edge approaches
and innovations. The Program also incorporates the wider University and extramural resources to deploy
multidisciplinary technologies with outstanding collaborators. Together, we expect our Program to provide a
transformative paradigm for true progenitor epithelial cell programming and its role in cell proliferation and
differentiation, including skewing towards mucous cell formation and excess mucus production that is central to
airway disease. We also fully expect that our studies will identify the first tractable cellular and molecular targets
and corresponding therapeutic intervention to attenuate airway disease, consistent with the mission of NHLBI.

Public health relevance
Relevance Chronic respiratory disease is a leading cause of death in the U.S. and worldwide and the morbidity and mortality are closely linked to excess production of airway mucus. Despite the scope of this problem, there are no specific and effective therapies for prevention or reversal of this abnormality. The proposed studies aim to define and control the pathways leading to airway disease and thereby address a previously unmet need for treatment of a major public health problem.